Viral vector-mediated gene activation to facilitate large-scale genetic analysis in Caenorhabditis elegans.

Project Summary
Fulfilling the promise of modern systems biology and grasping the underlying complexity of biological systems
requires a foundation built upon the development of high-throughput functional genomic approaches capable of
generating large datasets. Large scale sequencing efforts reveal correlations, but lacks causal interactions
best provided via genetic approaches. Caenorhabditis elegans has been a workhorse for gene discovery and
pathway analysis, and is the only established system where high-throughput genetic analysis can be
conducted in the context of a living multi-cellular organism (i.e. feeding based RNAi). Despite the power of this
model system, no high-throughput methods to achieve targeted gene overexpression in C. elegans have been
developed. This project will explore how recombinant strains of two different viruses can be adapted as vectors
to enable large-scale genetic analysis of gene overexpression in C. elegans. The objective of Specific Aim 1 is
to achieve promoter-specific gene activation using CRISPRa. This variant form of CRISPR relies on a
cleavage defective isoform of Cas9 (dCas9) fused with a transcriptional activator to drive overexpression of a
gene targeted by the single gene RNA (sgRNA). Specifically, we propose to generate proof-of-principle
evidence that recombinant vesicular stomatitis virus (rVSV) can deliver a sgRNA into transgenic C. elegans
that express the CRISPRa machinery in intestinal cells to induce sgRNA-directed overexpression of a reporter
gene. Ultimately our goal is to develop a comprehensive sgRNA VSV library directed to promoter regions to
allow high-throughput functional genomic screening in C. elegans. The objective of Specific Aim 2 is to develop
Orsay virus (OV) as a vector to deliver functional mRNA exogenously into C. elegans. The use of OV as a
gene delivery system is straightforward as this virus readily enters the animal via the intestinal lumen, and C.
elegans expressing integrated segments of the OV genome have been validated. Briefly, we will use these
existing strains as “packaging lines” to express C. elegans genes of interest capable of being incorporated in
newly generated virion to infect recipient nematodes. These studies represent an initial step towards the use of
OV as an overexpression vector and would accelerate the development large-scale genetic analysis in this
multicellular organism. These viral-based expression tools would integrate easily with existing approaches
widely used by the C. elegans community, which could potentially transform multiple areas of scientific
investigation, and has implications for understanding of many diseases.

Public health relevance
Caenorhabditis elegans has been a workhorse for gene discovery and pathway analysis, and is the only established system where high-throughput genetic analysis can be conducted in the context of a living multi-cellular organism. The goal of this research is to develop viral vector-based technologies to facilitate large scale genetic screens based on targeted gene overexpression, which would be of wide interest within the C. elegans community and fuel years of genetic discovery across a range of disciplines. Our goals are to achieve targeted gene activation in C. elegans using vesicular stomatitis virus to deliver a single guide RNA (CRISPRa), and to develop Orsay virus as a vector to exogenously deliver genes of interest into C. elegans.